Healthy Idaho Clinical & Translational Research Development Program

Enter the text here that is the new abstract information for your application.
The overall goal of the Healthy Idaho Clinical & Translational Research Development (CTR-D) Program is to build a foundation that supports clinical and translational (C&T) research, workforce development, and infrastructure enhancements to address the health needs of Idahoans. The need for C&T research development is so great in Idaho, that not one of the participating institutions feels qualified to lead the CTR-D program alone. Therefore, jointly, it was decided that four institutions would go forward, as a united entity to form the Healthy Idaho CTR-D program. Boise State University will be the lead applicant institution, joined by the lead institution, Idaho State University. Two partnering institutions include the University of Idaho and the Boise Veterans Affairs Regional Medical Center. Importantly, we will work with four clinical affiliates (affiliate health systems), Kootenai Health, the Idaho Community Health Centers Association, Saint Alphonsus Regional Medical Center, and St. Luke’s Health System. Based upon previous interactions between the four partnering organizations and the clinical affiliates, the Healthy Idaho CTR-D program’s three goals include: i) increase collaborative and multidisciplinary C&T research between, and at each, participating institution; ii) grow the C&T research workforce, while providing workforce development to academic and clinician investigators; iii) develop infrastructure needed to support C&T that targets healthcare needs and addresses common barriers. To address these goals, two aims have been developed: (1) Achieve the unified goals of the Healthy Idaho CTR-D program; and (2) Provide an overall organizational structure and governance to administer the program. To meet these aims, the CTR-D program has identified barriers to C&T research and will integrate creative and novel mechanisms and activities designed and carried out by the program Cores. The Healthy Idaho CTR-D program, including the four participating institutions and five program Cores, will be effectively managed using robust organization structure and governance. A strong management plan and communication structure are in place to allow all institutions and Core personnel to be involved in strategic improvements. In conclusion, the overall goal of the Healthy Idaho CTR-D program to build a foundation that supports C&T research, workforce development, and infrastructure enhancements will be an important step toward improving the health needs of Idahoans.

Public health relevance
The proposed Healthy Idaho Clinical and Translational Research Development (CTR-D) Program will enable academic institutions and their affiliate healthcare partners to develop clinical and translational (C&T) research. Through workforce development and enhanced infrastructure, the CTR-D program will better serve the health challenges faced by the people in the state of Idaho.